Precision Medicine Approach to Exercise-Based Interventions for Veterans with Knee Osteoarthritis

Background: Knee osteoarthritis (OA) is a leading cause of pain and disability, and Veterans have markedly
greater rates than non-Veterans. Exercise is a core component of care for knee OA, associated with modest
average improvements in pain and function. However, there is tremendous variability in the degree of
improvement individual patients experience following exercise-based interventions for knee OA. Further, there
are different types of exercise-based interventions for knee OA, ranging from self-directed programs to
individual physical therapy (PT), and it is likely that any given patient will not experience the same magnitude
of response to each of these different approaches. The overall objective of our research is to improve the
effectiveness, efficiency and patient-centeredness of exercise-based services for Veterans with knee OA
through a precision medicine approach that matches the intervention type with key patient characteristics.
Significance / Impact: There is currently no guidance or evidence regarding which patients benefit most from
different exercise-based interventions for knee OA. Thus, there is no clarity regarding which patients should
be directed to different types of exercise-based services.
Innovation: This will be the first study to examine heterogeneity of treatment effects in the context of different
exercise-based interventions among Veterans with knee OA. Methods will involve novel, robust machine
learning analyses.
Specific Aims: 1. Develop a precision medicine treatment strategy that optimizes improvement in pain,
stiffness and function, measured by the Western Ontario and McMaster Universities Osteoarthritis Index
(WOMAC), by tailoring exercise-based treatment to individual patients with knee OA. Aim 1.a. Use a causal
inference-based machine learning (ML) approach to estimate patient-specific estimates of treatment outcomes
(improvement in WOMAC scores) for each of the four treatments (Group PT, Individual PT, STEP-KOA, and
health education control). Aim 1.b. Apply uplift tree ML modeling to produce an interpretable tree-based model
for optimal assignment of treatment for knee OA. Aim 2. Apply results of ML analyses, along with a robust
partner-engaged development process, to design a randomized clinical trial (RCT) that will test the
effectiveness and cost-effectiveness of a precision medicine approach to delivering exercise-based
interventions to Veterans with knee OA.
Methodology: This project will involve analysis of two VA RCTs. One RCT compared Group vs. Individual PT
and found comparable overall mean improvements in pain and function. The second RCT examined the STEP-
KOA intervention, which begins with home-based exercise and progresses to PT only if participants do not
make clinically relevant improvements; STEP-KOA was also associated with mean improvements in pain and
function. Individual PT, Group PT, and STEP-KOA are all evidence-based interventions for knee OA, varying
in the amount and type of support provided to patients and therefore the associated costs to the VA. We are
preparing to scale Group PT and STEP-KOA in the VA. However, because Veterans in our RCTs varied
substantially in their degree of improvement following these interventions, we believe these programs will
ultimately be of much higher value to the VA and Veterans if we are able to target their delivery using a
precision medicine approach. In this project, we will apply robust ML approaches to uncover subgroups of
patients who benefit most (and least) from Individual PT, Group PT and STEP-KOA.
Next Steps / Implementation: Study results will directly inform an RCT that will test whether a precision
medicine approach is more effective than a “one size fits all” approach. Specifically, we plan for a 2-arm
pragmatic trial that will compare Individual PT for all patients (current standard of care) with a precision
medicine arm that assigns patients to one of three exercise-based interventions, based on key characteristics.

Public health relevance
This project focuses on knee osteoarthritis, one of the most common causes of pain and disability among Veterans. Exercise-based interventions, including physical therapy, help to improve pain and function for people with osteoarthritis. However, people with osteoarthritis vary widely regarding how much benefit they gain from different exercise interventions. In this study, we will analyze data from previous studies of three different exercise-based interventions for Veterans with knee osteoarthritis. Our goal is to uncover patient characteristics that predict how much individuals improve after completing these different exercise-based interventions. This information can ultimately be used to help the VA and clinicians to guide Veterans with knee osteoarthritis toward the specific type of exercise-based intervention that may help them achieve the most improvement in symptoms and function.